Human Tissue & Animal Core Unit

Core B will have three specific aims. Specific Aim 1 is to harvest, characterize and propagate human lung microvascular endothelial cells from subjects undergoing lobectomy or pneumonectomy at MCG Health Inc.;provide said cells to investigators in all four projects for permeability, analytical and other molecular studies. Specific Aim 2 is to create and supply to all four projects mice with ALI induced by intra-tracheal instillation of gram positive or gram negative bacterial products. Specific Aim 3 is to perform in vivo lung capillary permeability (Evan's Blue Dye Method) measurements and lung function (airway mechanics) measurements for studies designed by each of the four projects.

Public health relevance
RELEVANCE (See instructions): The goal of this Core is to help the four studies develop new approaches to the management of acute lung injury and acute respiratory distress syndrome, conditions that carry a high degree of mortality. It will provide the tools needed to investigate means of restoring the known dysfunction and increased permeability of lung capillary vessels.